The role of And-1 in nucleotide excision repair

Project Summary
Nucleotide excision repair (NER) is the major pathway to remove bulky DNA lesions induced by UV irradiation,
environmental mutagens, and chemotherapeutic agents. Deficiency of genes involved in NER has been linked
to Xeroderma Pigmentosum (XP) and skin cancer. There are two mechanisms to detect DNA damage by NER,
one is global genome NER(GG-NER) and another is transcription-coupled NER(TC-NER). GG-NER occurs
anywhere in the genome, whereas TC-NER is responsible for the accelerated repair of lesions in the
transcribed strand of active genes. The both pathways are divided into early and late steps. The early step is
the sequential actions, in which XP proteins recognize, unwind, and incise the DNA lesion. The latter step is
identical in both mechanisms and is characterized by gap-filling repair synthesis, in which DNA replication
proteins fill in the ~30 nucleotide gap, followed by ligation. Compared to the well-characterized early step, the
molecular mechanism regulating the activation of gap-filling DNA synthesis at late step remains largely
unknown. Even less is known about the physiological impact of such a regulatory pathway.
And-1 is an acidic nucleoplasmic DNA-binding protein and its yeast ortholog, Ctf4, was originally
identified as a critical gene for chromosome stability. Interestingly, yeast cells with depletion of Ctf4 gene are
hypersensitive to UV lights, suggesting a role of And-1 in UV-induced DNA damage response. However, how
And-1 regulates NER remains largely unknown. In this study, we now have extensive preliminary data
demonstrating that And-1 is critical for NER by regulating gap-filling DNA synthesis. Our hypothesis is that
And-1 regulates DNA polymerase activity at UV-lesion sites to activate gap-filling DNA synthesis at the late
stage of NER. To test this hypothesis, we plan to pursue three specific aims. Aim 1: Determine the mechanism
by which And-1 regulates DNA polymerase activity in NER. Aim 2: Determine the unique mechanism by which
And-1 is recruited to UV-lesion sites. Aim 3: Determine the role of And-1 in NER and skin tumorigenesis using
And-1 deficient mouse models. The completion of proposed studies will not only advance the field by
uncovering a novel And-1-mediated pathway to regulate NER, but also provide us with the in vivo evidence to
elucidate a novel role of And-1 in NER and skin tumor.

Public health relevance
Project Narrative Deficiency of genes involved in nuclear excision repair (NER) has been linked to Xeroderma Pigmentosum (XP) and cancers including skin cancer, however the mechanism regulating NER is not fully understood. This application is aimed to uncover a novel And-1-mediated pathway regulating NER and skin tumorigenesis. The proposed study will help to understand how skin tumor is initiated and benefit the development of therapeutic approach to treat skin tumor.